Determinants of geographic disparities in mortality and multimorbidity in the U.S.

Statement of Work
There is a fundamental gap in understanding the nature of interregional differences in health outcomes and
longevity in the U.S.: people in certain U.S. states and counties live up to 3.5 years (males) and 4.6 years
(females) less than in states with better health outcomes. The persistence, and even widening, of this gap over
time represents an important problem for the U.S. health system. These geographic disparities are associated
with increased burden of disease, increased health expenditures in the health-care system, and showcase an
observed lag in health and longevity compared to other industrialized nations. The objective of this application
is to identify the mechanisms underlying the observed geographic disparities and clarify the role clinic- and
non-clinic-related factors play in them. We expect that these geographic differences can be observed in
individual Medicare trajectories and that the size and scope of the 5% Medicare dataset supplemented by
Medicare records linked to the Health and Retirement Study will allow us to discover the causes of such
disparities. In this project, we will test four scenarios on how these disparities could be reflected in health
measures extracted from Medicare data: the regions with lower life expectancy exhibit higher disease
incidence (scenario #1), worse patient survival (scenario #2), higher multimorbidity (scenario #3), and/or worse
health state of individuals aged 65 (i.e., at time of entry into the Medicare system) (scenario #4). In Aim 1 we
will test in what extent each scenario (or their combinations) can explain observed geographic disparities in
mortality. We will identify specific diseases that contribute most to health disparities through each of the
scenarios to be studied. In Aim 2, we will identify how clinic-related characteristics such as use of specific
treatments, treatment choice and adherence to treatment, utilization of screening and diagnostic procedures
(especially for early-stage diagnostics) impact the health outcomes and contribute to geographic disparities.
Finally, in Aim 3 we will identify how non-clinic-related factors such as socioeconomic, behavioral,
environmental characteristics, and access to and quality of care measures (constructed from 5%-Medicare
data) impact the clinical measures identified in Aim 2 as determinants of geographic disparities. The results will
provide new knowledge about clinic- and non-clinic-related barriers to improvement of health and increase of
life expectancy in underperforming U.S. regions, identify the most affected population groups, and explain the
role of the clinic and non-clinic-related factors in morbidity and mortality trends. The results of the proposed
study will make possible the next step in approaching our long-term goal: to improve strategies of disease
prevention, optimize allocations of medical resources with the focus on underprivileged communities and to
improve health care standards to slow down or stop the growing gap in health disparities in the U.S.

Public health relevance
Project Narrative The proposed research is relevant to public health: identification of lagging (with life expectancy lower than the U.S. average) and leading (with life expectancy above the U.S. average) states, and evaluation of contributing factors behind them will ultimately inform the design of the strategies to improve public health and healthcare systems. That helps more effectively address health and life expectancy in the U.S. Thus, the proposed research is relevant to the part of NIH mission that pertains to developing fundamental knowledge on the reasons of recent deceleration in progress in the U.S. health and life expectancy.